IMMUNE RESPONSES TO OCULAR ANTIGENS

Targeted at learning about inflammatory eye diseases grouped under the term "uveitis," this project continued to focus mainly on learning about ocular antigens capable of inducing experimental autoimmune uveoretinitis (EAU), an animal model for uveitis in humans, and procedures that modulate this disease. The major achievements of this project in FY 1994 include: (1) We discovered that recoverin, a retinal calcium-binding protein, is hig y uveitogenic in rats, producing severe inflammatory changes in eyes of rats of all four strains tested. In addition to identifying a new uveitogenic retinal molecule, this observation provides evidence to support the assumption that recoverin is the target for an autoimmune process that causes a condition termed cancer-associated retinopathy (CAR). (2) Recombinant human S-antigen, which has become available by recombinant deoxyribonucleic acid (DNA) technologies, was found to be uveitogenic in primates, inducing severe inflammatory ocular changes that closely resemble those induced by bovine S-antigen. Lymphocytes from the immunized monkeys were used to identify the peptides that are selected as the immunodominant determinants, i.e., the ones that are the target for the immune response in animals immunized with the whole protein. Monkeys of different species responded against different peptides, whereas four monkeys of the same species (cynomolgus) remarkably responded against the same selected peptides. (3) Blood lymphocytes collected at different time points from a human donor exhibited consistency in their responding strongly to the same selected peptides of human S-antigen. Yet, marked changes were observed in the capacity of individual dominant peptides to stimulate lymphocytes collected at different time points. (4) To examine t effect of sequestration on the immunogenicity of lens proteins, transgenic (TG) mice were developed in which foreign antigens are selectively expressed in the lens. Two different types of response were observed: mice expressing chloramphenicol aminotransferase (CAT) responded to this antigen similarly to their wildtype controls, while TG mice expressing hen egg lysozyme (HEL) failed to respond against this antigen, due to a state of complete immunotolerance. (5) Oral tolerance, a procedure used to inhib pathogenic autoimmune processes, was found to be enhanced by treating the fed animals with certain bacterial products, with the best effect achieved with glucosaminyl muramyl dipeptide (GMDP). (6) The role of CD8 lymphocytes in the process of oral tolerance induction was examined by testing the capacity of mice deficient in these cells to develop oral tolerance. CD8 deficient mice resembled their controls in developing tolerance, thus showing that CD8 cells are not always essential for inducti of oral tolerance.